HIV-1 mucosal transmission and persistence

PROJECT SUMMARY
The goal of this midcareer investigator award is to establish protected time through which I can direct greater
focus towards mentoring young investigators interested in conducting patient oriented HIV-1 research. I am an
internist trained in infectious disease with research that focuses on mucosal HIV-1 transmission and
persistence. My career passion has always been to conduct patient oriented research that may ultimately
improve diagnostics, treatment, or prevention of disease. Receipt of outstanding mentoring during various
stages of my training allowed me to become a physician investigator and pursue my passion. My research
primarily focuses on topics deemed high priority areas by the National Institutes of Health and relevant for
patient health. Specifically, aims of this proposal will elucidate mechanisms for HIV-1 mucosal acquisition, the
most common mode of transmission in the world. My group has identified novel epithelial-based cells that are
potentially the first cell infected after mucosal exposure. R01AI122209 and this award will allow me to mentor
trainees in examining how these unique epithelial cells impact the types of virus that establish infection in
exposed hosts and how these cells can be source of the virus that re-emerges among virologically suppressed
patients that stop taking antiretroviral therapy. I am also a practicing clinician, and in clinical practice, it has
been noted that HIV infected patients are getting older and majority of patients suffer from HIV associated non
AIDS (HANA) conditions, such as atherosclerosis, neurocognitive decline, and renal pathology. While studies
have shown that systemic inflammation associates with HANA conditions, mechanisms for persistent
inflammatory state in the absence of peripheral virus replication remain unknown. R01AG060890 along with
this award will fund young-investigators to understand how HIV-1 expression from persistently infected cells
induces systemic inflammation. This understanding will provide important information for developing novel
therapeutic strategies aimed at ameliorating the burden of HANA diseases. We have also developed a novel
antibody dependent cellular cytotoxicity (ADCC) assay because this antibody functionality has been deemed
important in preventing transmission and decreasing the persistence of infected cells. R21AI137119 will fund
optimization of the ADCC assay, and this optimized assay will be used to examine its role in preventing breast
milk transmission by reducing the number of cells harboring infectious virus. K24 funds will allow me to pursue
these patient oriented research aims, and it will augment my ability to train the next generation of researchers,
especially clinician-scientists, so that they may gain skills in modern scientific methods to make an impact on
human disease. At this time, there is a special need for future clinician-scientists because clinically trained
physicians are often not pursuing research after their clinical training. I am particularly suited to accomplish this
goal because I have trained numerous young investigators, including clinician-scientists, who have gone on to
have independent research careers.

Public health relevance
PROJECT NARRATIVE This midcareer investigator award will allow Dr. Sagar to mentor junior investigators interested in conducting patient oriented research on two of the most important topics in the HIV field, namely transmission and persistence. The proposed work will examine mechanisms of HIV mucosal acquisition and the role of antibodies in preventing this transmission and decreasing persistence. Furthermore, aims will examine association between HIV expression from persistently infected cells and the systemic inflammation associated with HIV associated non-AIDS (HANA) conditions, which constitute the major morbidities for infected patients in this highly effective antiretroviral treatment era.